Impact of Amygdala Lateralization on Processing and Modulation of Bladder Pain

PROJECT SUMMARY
Urologic chronic pelvic pain syndrome (UCPPS) represents the most common type of chronic visceral pain
disorder. Although dysregulation of peripheral inputs from the viscera likely account for a number of the
symptoms UCPPS, a failure to understand and treat central nervous system (CNS) changes likely prevents
complete recovery for affected patients. The long-term goal of our lab is to understand the extent to which
areas in the brain are responsible for the development and maintenance of persistent pain and accompanying
affective disturbances that exist within urologic conditions. Recent evidence has suggested that the central
amygdala in the CNS may be an important locus for the interaction between visceral pain and anxiety,
potentially serving as a driver for chronic conditions like UCPPS. By determining the role of the amygdala in
animal models of bladder pain, insight will be provided into the underlying physiology of the human condition.
Evidence from human and animal models has shown that the left and right amygdala may differentially
regulate pain. Variances in left and right hemisphere activation are well described in human language
production, visual processing, and complex planning tasks. Functional lateralization exists in emotional
processing areas of the brain, including the amygdala, across multiple taxa where the right brain serves as a
reactive center to stress and injury. This conservation suggests that lateralization of limbic circuits is an
evolutionarily important phenomenon. The idea that dysregulation in lateralization might also play a significant
role in disease is a novel concept with clinical relevance. UCPPS patients show lateralized changes in
amygdala gray matter and lateralized amygdala functional connectivity to other areas in the CNS. We recently
identified a key molecular mediator through which lateralization of the amygdala modulates bladder pain bi-
directionally in mice depending on the side of the brain this neuropeptide is applied. The objective of this
proposal is to dissect the impact of this neuropeptide during the transition of acute to persistent bladder pain in
a rodent model including exploring the efferent circuits from the amygdala that mediate brain-induced
analgesia or hyperalgesia for bladder pain. This objective will be met through three distinct but complementary
specific aims. In Aim 1, we will determine the extent to which the development of persistent bladder pain alters
left versus right amygdala lateralization. In Aim 2, we will manipulate specific efferent outputs from the
amygdala to identify the unique analgesic versus hyperalgesic pathways. In Aim 3, we will incorporate new and
existing physiology data to develop a realistic 3-dimensional computational model of the amygdala that can be
used to predict laboratory results to progress bladder pain studies and therapies. Overall, this proposal will
help determine the extent and mechanisms of amygdala activation during painful bladder stimulation and the
mechanisms by which an overactive amygdala may contribute to bladder pain as seen in UCPPS.

Public health relevance
PROJECT NARRATIVE Patients suffering from urologic chronic pelvic pain syndrome (UCPPS) in the form of interstitial cystitis/bladder pain syndrome (IC/BPS) or chronic prostatitis/chronic pelvic pain syndrome (CP/CPPS) have an extremely poor quality of life due, in part, to the cognitive and emotional problems that accompany their pelvic pain and a lack of effective treatments. To learn more about the brain’s role in bladder pain in the hopes of finding new therapeutic targets, we focus on the amygdala, a brain area involved in both pain and emotion. These proposed studies will investigate the role of the left versus right amygdala in contributing to and altering bladder pain in mice.